Elucidating the Role of Gαz in the Behavioral Response to Opioids

Project Summary/Abstract
Chronic pain and pain-related diseases affect more than 50 million adults in the United States. Most of
the available pain therapies, including opioids, carry severe risks, such as the development of physical
dependence and addiction. This lack of broadly effective and safe pain medications necessitates the search for
novel pain management therapeutics. The identification of signaling proteins downstream of mu-opioid
receptor (MOR) may provide a way to optimize the actions of opioid analgesics by promoting signaling
pathways mediating analgesia, but not addiction-like behaviors. Previous work from our lab identified members
of the G alpha (Gα) family and Regulator of G protein Signaling (RGS) protein family that are essential for the
antinociceptive effects of multiple clinically used opioids. These include the G alpha z (Gαz) protein, an
understudied member of the Gαi/o family, which preliminary data suggest plays a central role in the mouse
ventrolateral periaqueductal gray (vlPAG) in mediating functional responses to MOR agonists in models of
acute pain. Based on preliminary data, we hypothesize that Gαz mediates MOR signaling in a brain region-
specific manner, and we will determine if Gαz signaling is involved in multiple behavioral effects of clinically
prescribed opioids, or if it selectively modulates antinociceptive responses. To test this, we will utilize
conditional knockout models to downregulate Gαz in the vlPAG and in the nucleus accumbens (NAc), a key
component of the reward pathway, and investigate its regional role on the various behavioral and biochemical
responses to opioids. In Aim 1, we will use qPCR, western blot analysis, RNAscope, and RNA sequencing to
characterize the expression of Gαz and downstream pathways mediating response to opioids in the PAG and
NAc. In Aim 2, we will use stereotaxic surgery, transgenic mouse lines, behavioral assays, and models of post-
operative pain to determine the region-specific role of Gαz in the behavioral responses to opioids. We will use
the hot plate assay to measure opioid antinociception, the Hargreaves assay to measure thermal hyperalgesia
following opioid treatment, and the Conditioned Place Preference assay to measure opioid reward. To monitor
sensory and affective signs of opioid withdrawal, we will use the Hargreaves assay, the marble-burying assay,
the light-dark box assay, and the novelty suppressed feeding paradigm. We will also use the paw-incision
model to determine the role of Gαz on opioid antinociception under pain states. Data collected from this
proposal will provide a comprehensive understanding of the region and cell-specific role of Gαz signaling in
response to opioids, contributing to the search for more efficacious and less deleterious pain medications. In
addition, our proposed plan provides an opportunity for diverse training in molecular, cellular, and behavioral
neuroscience, combined with bioinformatics and translational medicine, which will hone the skills required for
success as an independent physician scientist.

Public health relevance
Project Narrative As of 2023, more than 20% of all adults in the United States suffer from chronic pain, and it is the number one cause of disease burden and disability worldwide, yet current treatments for chronic pain are ineffective for a large percentage of patients, and some treatments, such as opioids, carry high risks of adverse effects and addiction. This proposal aims to investigate a novel molecular pathway that mediates functional responses to clinically used opioid analgesics. Understanding the brain region specific function and regulation of Gαz, an understudied G protein downstream of the µ-opioid receptor, will better guide therapeutic interventions for safer and more effective opioid treatments.